Real World Adoption of an OUD Digital Health Therapeutic

PROJECT SUMMARY / ABSTRACT
The opioid crisis is an epidemic with devastating health, social, and economic consequences for the United
States. In 2020, 2.7 million people over the age of 12 were reported to suffer from opioid use disorder (OUD).
The total economic burden of the opioid crisis in the US was recently estimated to be nearly $1.5 trillion.
Treatment for OUD involves medication (MOUD) combined with counseling or behavioral therapy to
manage the illness, achieve and sustain better health, and improve quality of life. Rates of recurrent drug use
are high, and access to counseling is limited and costly. While MOUD is standard of care and highly effective
at reducing acute morbidity and mortality, there are advantages to treatment approaches tailored to address an
individual patient’s drug use patterns and drug-related medical, psychiatric, and social problems. While mobile
tools exist to support OUD treatment, these products offer only generalized information and not personalized
feedback that is responsive to each person’s current status to support his/her individual recovery.
In a currently funded NIDA Phase II STTR grant, we are clinically evaluating KIOS, an innovative software
platform using nonlinear control theory, to satisfy requirements for FDA 510(k) device clearance. KIOS is a
digital health therapeutic that tracks multiple interacting symptoms (e.g., craving, mood, pain) to map patient
trajectories and deliver timely evidence-based intervention strategies, responding directly to patient-reported
needs. Accessible via mobile devices, KIOS provides patients on demand individualized advice and
reinforcement of lifestyle interventions to improve self-management concomitant to MOUD. This proposed
Fast-Track project is the next step in the development of KIOS, designed to demonstrate its real-world
adoption including endpoints to support positive coverage decisions from payors. This innovative tool to help
patients manage OUD has the potential to have a profound impact on public health and achieve significant
commercial success.
Phase I of this application examines barriers and facilitators to payor and other non-patient stakeholder
adoption, and incorporates the results into the software and trial design accordingly. It has three Specific Aims:
Aim 1. Perform Rapid Qualitative Analysis to Define Stakeholder Needs
Aim 2. Implement Applicable Software Changes
Aim 3. Finalize Clinical Trial Design for Phase II
Phase II evaluates the effectiveness of KIOS in clinical studies using a hybrid type 2 design. The Phase II
effort is comprised of three Specific Aims:
Aim 1. Optimize Implementation Program
Aim 2. Demonstrate Effectiveness in a Randomized Clinical Trial
Aim 3. Examine Implementation of KIOS in a Real World Context

Public health relevance
PROJECT NARRATIVE Behavioral therapy is an important adjunct to medication assisted treatment for opioid use disorder. Currently available mobile tools to deliver behavioral interventions are limited in their ability to respond to changing conditions of individuals in recovery. This project seeks to develop on demand delivery of mobile intervention strategies responsive to patients’ specific needs that if successful, would improve outcomes, reduce healthcare costs, and have a significant impact on public health.